Tulane University COVID Antibody and Immunity Network (TUCAIN)

Overall Summary
The SARS-CoV-2 virus, the causative agent of COVID-19, has infected a reported 13,810,247 persons globally
as of July 16, 2020 with a mortality rate of 4.2%. In the State of Louisiana, over 7.3% of the 86,411 COVID-19
cases involve people living with cancer. Theoretically, convalescent plasma contains protective antibodies that
neutralizes virus and mitigates its pathogenic effects. Yet, there remains a large gap in our understanding of the
mechanisms that drive humoral and cellular immune responses and how these responses correlate with disease
course and protection as well as the durability of those responses. Furthermore, there is a need for serological
assays that measure these responses accurately for serodiagnosis and as correlates of immunity and protection.
Without this knowledge, the true efficacy of convalescent plasma as therapy for COVID-19 and our
understanding of the humoral immune response to SARS-CoV-2, especially in immunocompromised patients,
will remain unknown.
The overall goal of the Tulane University Convalescent Antibody and Immunity Network (TUCAIN) is to
characterize this response with respect to functionality and durability. We will achieve this goal by investigating
the following broad specific aims: (1) Characterize the evolution, function and longevity of the humoral immune
response to COVID-19. (2) Identify cell mediated immune responses that contribute to durable or short-lived
humoral immunity to SARS CoV-2. (3) Correlate protective and potentially pathogenic immune responses to the
clinical course of hospitalized COVID-19 patients. We will achieve these goals by studying a diverse cohort of
COVID-19 survivors and minimally sick seroconverters, including a large cohort of patients with malignancies.
Using serial blood collections, we will apply several immunological technologies to study the evolution and
durability of the immune response over time. We will also correlate these responses to patient outcomes and
disease pathogenesis using a “big data”, systems biology approach. An approach, such as the one we propose,
will allow us to determine if COVID-19 survivors develop long-term, antibody-based protection and we can
confirm if convalescent plasma has therapeutic potential. This research will allow us to identify new targets for
medicines and vaccines, inform personalized treatment strategies such as those required by
immunocompromised patients with cancer, and to provide novel immunological algorithms applicable to a wide
range of human pathogens.

Public health relevance
Project Narrative SARS-CoV-2, the virus which causes COVID-19, is one of the most devastating human pathogens of our time. The Tulane University COVID Antibody and Immunity Network (TUCAIN) will mechanistically define the immune response to this virus to determine how it protects individuals from infection and how long that protection lasts. By creating large integrated data sets of immunological and clinical data as well as characterized blood samples, we will be able to construct sophisticated methods to diagnose, and improve treatment of infected individuals.